Aldehydes in Alcohol-Induced Organ Injury

Project Summary
Long-term heavy drinking causes multiple organ injury with the liver as the most impacted organ. Alcoholic liver
disease (ALD) covers a spectrum of liver lesions, including simple steatosis, alcoholic hepatitis and cirrhosis.
Unfortunately, FDA approved medication is not available for any stage of ALD. Thus, there is an urgent need to
investigate the mechanisms of disease pathogenesis and explore therapeutic strategies for ALD. Increasing
evidence support that translocation of pathogen associated molecular patterns (PAMP) from the intestine to
the liver triggers hepatic inflammation. During the past funding period, we investigated the role of type 1
conventional dendritic cells (cDC1s) in alcohol-induced defects at the gut-liver axis. We observed that Chronic
alcohol feeding reduced intestinal cDC1s and IL-12. In accordance, Th1 cells and their INF- expression were
also reduced. Batf3 knockout mice (cDC1 deficient) showed that cDC1 deficiency exaggerated alcohol-
reduced Th1/IFN- and worsened alcohol-induced dysbiosis, gut barrier dysfunction, PAMP translocation and
hepatic inflammation. Adaptive transfer of cDC1s reversed alcohol-decreased intestinal defects and
amelioration of ALD. We also found that IFN-γ administration restored intestinal STAT1 and STAT3,
upregulated AMPs, orchestrated gut microbiota, and reversed alcohol-induced endotoxemia and hepatic
inflammation. These results suggest that dysregulation of dendritic cell-T cell axis represents a novel
mechanism in alcohol-induced pathogenesis at the gut-liver axis. Our preliminary studies further demonstrated
that chronic alcohol feeding increased type 2 conventional dendritic cells (cDC2s) in the intestine, suggesting
an imbalance between cDC1 and cDC2 responses. cDC2s after antigen acquisition in the lamina propria
migrate to lymph tissues and induce Th17 cell differentiation. Indeed, we observed that CD4+IL-17+ T cells
(Th17 cells) were increased in the lymph tissues after alcohol exposure. We also found that alcohol increased
the dendritic cell surface succinate receptor, GPR91, in association with increased intestinal succinate. These
results suggest a novel host immunity-microbiota crosstalk mechanism in activation of cDC2s-Th17 cells circuit
in alcohol-induced pathogenesis at the gut-liver axis. This renewal project plans to investigate the role of DC2
activation and induction of Th17 response and the mechanism of how alcohol activate cDC2s in the
pathogenesis of ALD. The project will carry out three aims. Aim 1 is to determine the causal role of intestinal
cDC2 cell activation in alcohol-induced pathogenesis at the gut-liver axis. Aim 2 is to investigate a succinate-
activated GPR91 signaling pathway in alcohol-induced intestinal DC2 activation and migration. Aim 3 is to
determine the mechanisms by which alcohol elicits an intestinal succinate signal.

Public health relevance
PROJECT NARRATIVE Alcohol abuse impairs the intestinal mucosal immune system which plays a critical role in maintaining the equilibrium of a highly complex gut ecosystem. This project is to investigate the mechanisms of how alcohol abuse impairs the intestinal mucosal immune function and induces dysbiosis in the development of alcoholic liver disease. The goal of this project is to explore molecular targets for developing therapeutic interventions.